animal procurement

Commercial Animal Purchase of various strains and stocks of barrier-reared and maintained rats, mice, hamsters, gerbils, guinea pigs and/or rabbits, which meet the specific genotype, health status, sex, age, weight and /or pregnancy requirements and surgical manipulations, as included in the vendor's commercial catalog, website, or notification of availability. This contract is used for the procurement of various blood, tissue, organs and other biological specimens. Provides various specialized animal services, which may include, bit in not limited to: rederivation, cryopreservation, cryopreservation storage, quarantine, customized breeding, colony development, production and maintenance, animal health surveillance and diagnostic testing;genetic monitoring, diagnostic and testing services, veterinary services, customized research protocols, and rodent export and import services, as included in he vendor's commercial catalog, website, or notification of availability.